Wnt signaling in hematopoietic development

Project Summary/Abstract:
Hematopoietic stem cells (HSCs) give rise to all terminally differentiated cells in the blood. The ability of HSCs
to reconstitute these blood cell lineages for life underlies the efficacy of bone marrow transplantation therapy for
treatment of various blood disorders, including leukemias, anemia, and autoimmunity. Although this is an
established and effective treatment, two-thirds of patients in need of a transplant lack a matched donor.
Therefore, alternative sources of therapeutic HSCs would be a boon to the field. Human pluripotent stem cells
(hPSCs) represent a potential source for cell-based therapies, including the derivation of patient-specific
transplantable HSCs, which would additionally circumvent immune rejection and alloreactivity, both major issues
in the clinic.
The proposed collaborative research leverages the expertise of two Principal Investigators with complementary
research interests and skills in stem cell biology, zebrafish genetics and development, murine HSC biology,
hematopoietic development, and Wnt biology and biochemistry. Using zebrafish and hPSCs as model systems,
they seek to identify and characterize the molecular cues that direct hematopoietic development during early
embryonic stages, with an emphasis on the role of Wnt signaling. The proposed studies will build on their finding
that a signaling axis regulated by Wnt9a/Frizzled9/EGFR is specifically required for HSC emergence and
expansion across vertebrate phyla. This proposal will leverage lineage tracing methods in zebrafish and in vitro
differentiation protocols of hPSCs combined with single-cell sequencing approaches to determine the molecular
mechanisms of this requirement, and to provide a new level of understanding of how posterior lateral mesoderm
is instructed to generate HSCs.
The long-term goal of these studies is to gain a better understanding of how HSCs develop in the embryo in
order to translate this information to hPSCs. Successful completion of this research will have a profound impact
on HSC derivation and expansion, and thereby will be instrumental in overcoming current obstacles to the
effective treatment of diseases requiring bone marrow transplant therapy.

Public health relevance
Project Narrative Hematopoietic stem cells (HSCs) are rare cells within human bone marrow that are responsible both for the life-long replenishment of all blood cell lineages and for the curative effects of bone marrow transplantation. The creation of human induced pluripotent cells holds great promise for cellular regeneration therapies, but we cannot currently instruct these cells to specifically generate HSCs in vitro. The overall goal of this application is to determine the molecular cues and behaviors that instruct HSC fate in the vertebrate embryo and from human pluripotent stem cells such that these events may ultimately be replicated routinely to generate patient- specific HSCs for clinical utility.